Human Skin Disease Resource-based Center

Project Summary/Abstract: Overall Component
Mouse models have provided many biologic insights and remain the most popular system in which to conduct
skin disease research. However. there are significant differences between the skin and immune systems of
mice and humans and these differences are incompletely characterized, making it difficult to know if
observations made in mice will hold true in humans. Research carried out on human cells and tissues can
address this knowledge gap. Human biobanks and powerful new analytic techniques have become available
that make high-quality human skin disease research accessible. The goals of this Center are to accelerate
human skin disease research by providing researchers at any institution with access to human specimens and
cutting edge analytic techniques and to bring new diverse investigators into the field of human skin disease
research. We include 45 research projects from investigators who wish to utilize Center services; however, any
researcher wishing to carry out human skin disease research is a potential member of the research
community. The Center is composed of an Administrative Core and three Resource Cores. The Administrative
Core manages and oversees all activities of the Center and administers Diversity and Outreach activities,
including funding for diverse investigators at multiple stages of training and the biennial International
Conference on Human Skin Disease. The Human Tissues Biobank Core provides access to over 113,000
highly characterized consented patients, over 1.5 million banked pathologic specimens, both searchable by
diagnosis, as well as to fresh human skin, purified cell populations from human skin and immunodeficient mice
grafted with human skin and blood. The Single Cell and Immunoanalysis Core provides access to single cell
RNA and ATAC sequencing, flow cytometry-based single cell imaging, mass cytometry by time of flight
(CyTOF) and high throughput TCR sequencing. The Next Generation Tissue Analysis & Imaging Core
provides access to six color tyramide amplification based immunostaining combined with spectral imaging and
automated cell analysis, NanoString RNA and DNA profiling and Digital Spatial Profiling, a state-of-the-art
technique that that can profile expression of 10-1000s of protein or RNA targets in FFPE and frozen sections.
In summary, the Center provides access to biobanks and cutting-edge human analytic techniques that enable
translational researchers to carry out high quality human skin disease research.

Public health relevance
Narrative: Overall component Understanding the biology of human skin diseases is critical to alleviating suffering and curing these diseases in patients. However, mice and other animals are imperfect models for humans and many therapies developed in mice are not successful in humans. This Center will recruit, empower and support researchers at any institution who wish to work on human cells and tissues by providing access to human tissue biobanks and cutting edge analytic techniques that will allow them to carry out high-quality, human-based research that is directly relevant to human skin disease.